HEAT BEAM DOLORIMETRY OF ASSESSMENT OF PAIN

The intention of this study is to ascertain the objective relationship of HBD responsiveness (to incident pain) and endogenous pain reported by standard visual analog methods.